Interdisciplinary investigation of functional asymmetry and topological restructuring in mitochondrial networks during cellular aging

Project Summary
Age- and function-based positioning of mitochondria plays a critical and conserved role in cellular differentiation
and aging from yeast to humans. Evidence suggests that mitochondrial positioning mechanisms selectively
transport or retain specific mitochondria based on their fitness, resulting in physiological asymmetry between
mother and daughter cells. However, a major conceptual challenge is that mitochondria form connected
networks. They experience constant remodeling by mitochondrial fission and fusion, while their size continuously
expands during cell growth. The continuous mitochondrial content mixing should eliminate any differences
between mitochondria, making it difficult to explain how some mitochondria can be fitter than others. In this
proposal, we unite and integrate complementary expertise in mitochondrial biology, quantitative cell physiology,
and in silico modeling of organelle dynamics to mechanistically investigate the precise sequence of subcellular
events that lead to asymmetric mitochondrial segregation, first during the cell cycle and ultimately to replicative
aging. We will implement powerful molecular and single-cell techniques in combination with in silico modeling
approaches to control, track, and model individual mitochondria and their dynamics, topology, and function as
cells age. The true power and innovation of the proposed research is the tight integration of approaches guided
by novel mechanistic hypotheses of cellular aging. In Aim 1, we will test our model for the molecular basis of
fitness recognition, which centers on the role of cardiolipin (CL), a lipid linked to myriad mitochondrial functions.
We hypothesize that CL both enhances the import of mitochondrial components and is selectively recognized
by the mitochondrial transport and tethering proteins, providing a novel testable mechanism for the inheritance
of the fittest. We will test whether the tenets of our model enable the emergence of asymmetry in mitochondrial
content and function during the cell cycle and, in Aim 2, investigate the impact of that asymmetry on replicative
aging. In addition, we will consider the role of other organelles such as the vacuole. We will utilize the yeast
mother machine to reveal a hierarchy of age-related changes in mitochondria and vacuoles. The causal
relationship between cellular aging and age-dependent changes in mitochondria and the vacuole will be
determined. Our studies in yeast will uncover fundamental mechanisms used by cells to establish functional
asymmetry within mitochondrial networks. Therefore, this work has the potential to lead to novel therapeutic
strategies to slow or reverse aging in humans by manipulating the mitochondrial drivers of aging at the cellular
level.

Public health relevance
Project Narrative Aging is a process with which all organisms must contend, and mitochondria are a fundamental factor in both upstream and downstream events of cellular aging. However, many aging hypotheses related to mitochondria have remained unsolved, because our ability to control and track individual mitochondria and their morphology, genomes, functions, and interactions with other organelles as cells age has been limited. The goal of the proposed work is to implement powerful molecular and single-cell techniques in combination with in silico modeling approaches to address these limitations and gain new mechanistic insights into the role of mitochondria in cellular aging.